Core B - Clinical Core

Mount Sinai ADRC (Sano): Clinical Core (Core B) – Research Summary
The Clinical Core provides expertise in the clinical and biological characterization of diverse
individuals with and without cognitive loss. This expertise is utilized to recruit and maintain a
cohort of participants of varying clinical presentations, educational attainment, races and
ethnicities. This cohort supports a broad array of dementia and cognitive research conducted
within ISMMS, the Mount Sinai Health System, and national initiatives such as the National
Alzheimer’s Coordinating Center (NACC), Alzheimer's Therapeutic Research Institute (ATRI),
Alzheimer’s Clinical Trials Consortium (ACTC), Alzheimer’s Disease Cooperative Studies
(ADCS), the Alzheimer’s Disease Neuroimaging Initiative (ADNI). The role of the core is to
develop and implement clinical procedures and collect biomarkers for the high standard
characterization of elders spanning the spectrum of normal, prodromal, and various stages of
affected subjects into “research-ready” cohorts. The Clinical Core provides subjects, tissue, and
data for studies as well as clinical research expertise related to clinical manifestations of
disease, disease course, treatment responses, and recruitment feasibility to help guide the
design and implementation of studies within the Center and broadly within the MSHS. Within the
Center, the Clinical Core provides the essentials for research: the subjects and characterization
for the Imaging Biomarker and Genetics Fluid Biomarker Cores as well as the Neuropathology
Core; clinical and educational expertise to interact with the projects and trainees of the ORE and
REC cores. The Core innovates in the development of assessment tools; application of
assessments to new populations; adaptation of new imaging technologies into the clinical ‘real
world’; and facilitates work with clinical trials. The Core has a rich and successful history of
outreach to groups underrepresented in dementia research which remains a focus of this
application. The Core is active in training young investigators and supporting investigators from
other fields who wish to study cognition in their clinical populations.